Innovative Point-of-Use Water Purification System: Portable, Scalable, Efficient, Easy-Use

Innovative Point-of-Use Water Purification System: Portable, Scalable, Efficient, Easy-Use
Fresh water in lakes and rivers have supported societies for centuries, unfortunately most water in
nature is not drinkable due to the presence of various disease-causing pathogens.1 Modern cities have
extensive infrastructures to supply purified natural water for a functional society. When major climate
disastrous occur, their access to drinkable water is disrupted, diminishing their resilience. In 2023 so far,
25 catastrophic natural disasters have occurred, each costing the US well over a billion dollars. This is
highest number of consecutive events recorded since 1980 by the National Oceanic and Atmospheric
Administration (NOAA). The 2021 Texas winter storm resulted in ~14.9 million people experiencing water
disruptions. More frequent large magnitude nature disasters is expected with climate change. It is critical
to develop innovative technologies to provide easy access to drinkable water for individual citizens.
Reverse osmosis (RO) and chemical oxidant disinfection are the main approaches for point-of-use
(POU) water treatment in the commercial domain. However, the former requires pressurized water and is
susceptible to membrane fouling, and the latter employs oxidants, such as ozone, chlorine, and chlorine
dioxide, which could generate carcinogenic byproducts affecting people’s health. Recently, solar steaming
(SS) has become promising for POU renewable water purification; nevertheless, such devices depend on
weather and geographic locations and have limited accountability during extreme weather.
The overall project aims to develop a novel electric powered POU water treatment system that can
directly fish out live bacteria and remove toxic metal ions, such as Lead and Mercury, in natural water to
reach the drinkable level. The device will utilize the enhanced interactions between bacterial cells and a
designed high-frequency electric (E) field applied via highly-branched graphite foams to remove bacteria.
In a low-frequency E-field, the foam electrodes will generate electroomosis flows in water to readily augment
their absorption of toxic metal ions. As a step towards this goal, in this phase-I project, we will exploit an
economic, rational approach to fabricate an innovative highly branched graphite foam, and validate and
optimize its dual functions towards bacterial disinfection and metal-ion removal in designed AC electric
fields. The fabrication of the branched graphite foams will be carried out in a robust manner via leveraging
our patent-awarded technique (#11,858,816, 2023) to endow the foams with (a) densely branched
structures for bacterial alignment, propulsion, and capture, as well as (b) enhanced ionic absorption
capability for the removal of toxic ions.
Once successful, this project will deliver a portable, scalable, all-weather, easy-use water purification
solution for individual citizens, effectively enhancing society’s resilience in response to natural disasters.
1|Page

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Climate change is expected to lead to increased frequency and severity of global weather disasters. High- density population areas often experience significant disruptions in essential supplies, including water, during these events, making rescue operations extremely challenging. This project aims to create an innovative, point-of-use (POU) water purification solution for individuals and homes via fabricating and exploiting a unique highly-branched graphite foam and designed high-frequency electric fields to directly fish out bacteria and remove toxic metal ions in natural water sources, enabling scalable applications from personal cups to emergency water storage.